Georgetown University Lombardi Comprehensive Cancer Center Support Grant

Title: Transdisciplinary Research Targeting Metabolic Dysregulation to Improve Cancer and Aging
Outcomes
Abstract
This application is being submitted in response to “Administrative Supplements to Advance Development of
Transdisciplinary and Large-Scale Population Science and Cancer Control Research Projects (PA-20-272).
There are multiple interconnected pillars of cancer and aging, thus our goal is to focus on the root causes and
effects of metabolic dysregulation and to investigate the multidimensional relationships of the exposome in our
efforts to identify new mechanistic targets for cancer control. We will utilize a transdisciplinary collaborative
model to guide the development of a successful program project coupled with a strong scientific framework,
leading to new mechanistic insights that will support development of new cancer control paradigms to improve
cancer and aging health outcomes of metabolic dysregulation. Lombardi will build partnerships among its
researchers and Stakeholders, and reach across cancer centers to collaborate with Karmanos Cancer Institute
and other content-area specialists to mobilize unique transdisciplinary expertise and resources to develop three
synergistic projects and Core facilities. The projects use our conceptual biobehavioral framework to discover
pathways and generate novel data that guide targeted interventions to prevent cancer progression, improve
function of cancer survivors and ultimately increase survival. The overall goals of the planned program project
are to:1) discover how heterogeneity in health-related exposures (exposome) affect cancer and aging biological
processes and how dysregulation of metabolic processes affects cancer biology and 2) leverage these
mechanistic discoveries to guide and/or test interventions to improve cancer and aging outcomes. The aims of
the supplement are to:
Aim 1. Conduct a review of the research landscape to refine the program project concept and design; identify
and fill gaps in subject matter expertise though collaboration within and across cancer centers; maximize
synergy; and obtain critical feedback. Deliverables: finalizing the project team; submission of a review
manuscript; meetings with NCI staff; drafting of a P01; mock study section review and submission preparation.
Aim 2. Conduct additional preliminary studies to support each proposed project to demonstrate proof of principles
and team collaboration. Deliverables: use of results to guide final project development; submission of
collaborative meeting abstracts and manuscripts.
Aim 3. Evaluate what Cores already exist, determine what additional Core resources are needed; establish and
use the proposed new Core resources to support the team's activities. Deliverables: collaboration of proposed
Cores in preliminary studies and manuscripts.

Public health relevance
Project Narrative There are multiple interconnected pillars of cancer and aging, thus our goal is to focus on the root causes and effects of metabolic dysregulation, and to investigate the multidimensional relationships of the exposome in our efforts to improve cancer control. We will utilize a transdisciplinary collaborative model to guide the development of a successful program project coupled with a strong scientific framework, leading to new mechanistic insights that will support development of new cancer control paradigms to improve cancer and aging health outcomes of metabolic dysregulation. Lombardi Comprehensive Cancer Center will build partnerships among its researchers and Stakeholders, and reach across cancer centers and other content- area specialists to mobilize unique transdisciplinary expertise and resources to develop three synergistic projects and Core facilities.